Production Assistance for Cellular Therapies (PACT)- Cell Processing Facilities Cell manufacturing and process development services for PCT0031-02: GMP Production of iPSC Line and Scale-up of Cardiac

The purpose of this task order to provide cell manufacturing services to an approved PACT program requestor. Dr. Hare's CPF will provide clinical grade Cardiac progenitor cells and exosomes to the requestor, Dr. Ashraf. The project has undergone scientific merit review by an external, peer review board and administrative review by NHLBI PACT project/program officers.